Core A: Administrative Core

Core A, the Administrative Core of Mayo Clinic’s Hepatobiliary Cancer SPORE, will provide an overall
organizational infrastructure to encourage collaboration, manage finances, and coordinate the review of
progress of the research projects, scientific cores and developmental programs (Developmental Research
Program and Career Enhancement Program). The Administrative Core will also ensure optimal function of all
SPORE components and encourage communication between the SPORE, Mayo Clinic Cancer Center, Mayo
Clinic as a whole, other Hepatobiliary SPOREs, other Mayo SPOREs, SPORE collaborations with non-SPORE
funding instruments, and the National Cancer Institute. In addition, the Administrative Core will consult with the
members of the SPORE committees including the External and Internal Advisory boards in order to achieve
maximum potential for translational objectives. Core A’s specific aims are to: 1) Provide leadership and
collaboration between the Research Projects and Cores of the SPORE; 2) Assure incorporation and
participation of the Hepatobiliary Cancer SPORE in the activities of Mayo Clinic Cancer Center; 3) Establish
monthly meetings of SPORE investigators and the Internal Advisory Board; 4) Arrange yearly research retreats
and 2x/year meetings of the External Advisory Board; 5) Coordinate meetings of the Mayo Clinic Cancer
Center SPORE Directors’ Working Group as needed; 6) Provide administrative support to the Developmental
Research Program and to the Career Enhancement Program; 7) Facilitate investigator trips to relevant SPORE
meetings; 8) Enable activities of the Hepatobiliary Cancer SPORE advocates; 9) Prepare the yearly non-competing SPORE application; 10) Serve as the administrative liaison between the Mayo Clinic SPORE and
the NCI SPORE Program, other SPOREs, and collateral organizations; 11) Maintain the Mayo Hepatobiliary
Cancer SPORE Websites that will be useful to investigators inside and outside the SPORE, as well as
patients; 12) Coordinate information and communication about SPORE research developments to the Mayo
Clinic SPORE investigators, the scientific community at large, and the public.

Public health relevance
The Administrative Core will provide infrastructure for managing finances, planning meetings, booking travel arrangements, and communications. The objective is to support the SPORE’s goals in general operations, in order for the SPORE to function more efficiently; this will allow the translational scientific goals to be achieved and advances in superior patient care to be attained.